DEVELOPMENT OF STATISTICAL METHODOLOGY FOR THE ANALYSIS OF BLSA DATA

The theoretical development of statistical methodology is progressing in the areas of epidemiological models, multiple comparisons, survival analysis, and the design of experiments, each of which is applicable to longitudinal studies. The research utilizes various regression methods for prospective studies, Bayesian theory in conjunction with decision theory, and numerical computing methods. The methodology created provides original contributions to experimental testing associated with longitudinal studies, the simultaneous comparison of specified effects (e.g. treatments against a control or placebo), epidemiological study of disease states, survival or failure analysis of longitudinal data and other longitudinal observations representing growth and other physical changes of humans and animals. Accomplishments in the creative use of Bayesian theory in the area of multiple comparisons will fill a void in the established statistical armametarium.